Administration Core

ABSTRACT – ADMINISTRATIVE CORE
The overall goals of the Mayo Clinic SPORE in Ovarian Cancer are to stimulate innovative research in ovarian
cancer and to expedite the translation of discoveries into new and better methods of prevention, detection and
treatment of this disease. The Administrative Core has facilitated progress toward these goals by serving as the
organizational hub of the Mayo Ovarian SPORE during Years 6-10 of funding. Major changes during the past 5
years have included the i) development of a new co-leader, Jamie Bakkum-Gamez, for the Core, and
ii) recruitment of several new External Advisory Board (EAB) Members, reflecting new directions in the SPORE
projects. During the next funding period (Years 11-15), the Administrative Core will continue to provide
organizational and communications support for the SPORE leadership, research projects, scientific cores and
developmental programs [Developmental Research Program (DRP) and Career Enhancement Program (CEP)].
Specifically, the Administrative Core will: 1) Provide leadership and organizational support to SPORE
investigators; 2) oversee formal procedures for scientific review of SPORE research projects; 3) oversee and
facilitate the efforts of all cores; 4) manage and coordinate SPORE fiscal activities; 5) monitor accrual, including
minority accrual, to all Mayo Ovarian SPORE clinical trials, population research studies and biospecimen
collections; 6) provide guidance and administrative support to the DRP and CEP leadership; 7) facilitate the
activities of the Executive Committee and implement its decisions; 8) facilitate engagement of the SPORE
advocates; 9) facilitate reviews of the SPORE by the EAB and Internal Scientific Advisory Committee (ISAC);
10) organize monthly SPORE scientific meetings, seminars, and the annual retreat; 11) assure ongoing
integration of the Ovarian SPORE with the Mayo Clinic Cancer Center and its Women’s Cancer Program;
12) serve as the administrative liaison between the Mayo Ovarian SPORE, the NCI SPORE Program, other
Mayo SPOREs, and external collaborators; 13) identify and catalyze research collaborations in ovarian cancer,
including collaborations with the other Ovarian SPOREs; 14) communicate SPORE-related research
developments and opportunities to Mayo investigators; and 15) assist the SPORE Director in preparing reports
of Ovarian SPORE activities, including annual progress reports and the competitive renewal application.

Public health relevance
NARRATIVE – ADMINISTRATIVE CORE The Administration Core provides the organizational infrastructure necessary to perform the work proposed in this SPORE application.